Research Training Program in Metabolism, Obesity and Diabetes

Project Summary/Abstract
The problems of obesity and type 2 diabetes (T2DM) are some of the most common conditions affecting
Americans. There is a critical need to train the next generation of MD/DO and PhD investigators who will address
these public health challenges with innovations in basic, clinical and translational sciences. We believe that the
University of Colorado, Anschutz Medical Campus (UCAMC) is well positioned to provide the training needed to
produce the next generation of scientists addressing these areas. We are seeking continuing support for 4
positions (2 post-doctoral trainees to be supported for 2 years each) in the Research Training Program in
Metabolism, Obesity and T2DM (RTPMOD) at the UCAMC. The strength of the RTPMOD lies the outstanding
faculty, state of the art facilities and programs at the UCAMC and a robust pipeline of applicants. The 25
members of the Training Faculty are productive well-funded investigators, many of whom are nationally
recognized leaders in their fields of study who collectively have $16.5 million in current research funding (direct
costs current year). The UCAMC is host to the Colorado Clinical Translational Science Institute, the Colorado
Nutrition Obesity Research Center, the Denver Diabetes Research Center and the Anschutz Health & Wellness
Center to name just a few of the resources that will support the requested training. Over the last 4 years of this
first cycle of the new RTPMOD, 8 postdoctoral fellows have been supported. Two received F32 awards and
2 received K awards. All remain in research related or research-intensive positions. Two are Assistant
Professors. Applicants for the RTPMOD come from a range of clinical fellowship programs at UCAMC, our
clinical Obesity Medicine Fellowship, and the Physician Scientist Training Program track within our Internal
Medicine Training Program. PhD applicants come from local and national recruitment efforts. MD/DO and PhD
applicants are selected though a rigorous recruitment process designed to identify those with the greatest
promise to pursue an independent research career. In addition to an intensive mentored research experience,
trainees will gain formal training in metabolism, obesity and T2DM and team science. The program will be
administered by an experienced Program Director supported by an Executive Committee with input from a
independent External Advisory Board. We believe that the RTPMOD has shown early success in this first cycle
of funding and provides outstanding training for postdoctoral fellows seeking a long-term independent research
career in metabolism, obesity or T2DM research.

Public health relevance
Project Narrative There is a critical need to train new investigators to continue the scientific advances that have helped address the causes and health consequences of obesity and type 2 diabetes. This continuing renewal application for the Research Training Program in Metabolism, Obesity and Type 2 Diabetes leverages the skills of a group of talented, experienced and well-funded mentors with the state-of-the-art facilities and programs at the University of Colorado Anschutz Medical Center and a robust pipeline of outstanding MD/DO, MD/PhD and PhD candidates to train the next generation of independent academic researchers addressing these important public health challenges.